Mineral Coated Microparticles for Stabilization and Delivery of Complexed mRNA for Healing of Long Bone Defects

PROJECT SUMMARY / ABSTRACT
Age related traumatic and pathologic fractures are expected to increase greatly in incidence in the coming
decades with aging populations. Older patients are at higher risk for non-healing, ‘critical-size’, bone defects
following fracture. This is exacerbated in composite injuries with concomitant soft tissue defects. These require
multiple surgical interventions and still a majority of patients remain significantly disabled. Therapies, like
bone marrow aspirate concentrate (BMAC), or recombinant bone morphogenetic protein-2 are inconsistent
and ineffective or limited by dose related side effects, such as inflammation, respectively. These drawbacks
may be overcome by osteogenic stimulation with biomaterial platforms for non-viral gene delivery.
The Murphy laboratory has developed nanostructured mineral coated microparticles (MCM) that improve
and sustain delivery of therapeutic nucleic acid complexes. These biomimetic mineral coatings were inspired
by the structure and characteristics of fossils. Ancient DNA has been recovered from fossils which implicates
a role in mineralized surfaces preserving nucleic acids. New stabilization strategies are essential as current
mRNA products, like COVID-19 vaccines, require extensive cold-chain infrastructure limiting their
application. Biomimetic mineralized materials may provide a platform for the binding, long term stabilization,
and delivery of mRNA therapeutics.
This fellowship proposal will develop a biomaterials-based method for storage and delivery of mRNA
encoding for osteogenic growth factors and train the applicant for a career as a physician scientist. We
hypothesize that MCM delivery of mRNA can 1) improve mRNA transfection after lyophilization, 2) promote
an osteogenic phenotype in BMAC and 3) mRNA for osteogenic growth factors will reduce inflammation and
improve bone defect healing. Aim 1 will optimize and characterize how MCMs stabilize mRNA complexes
after lyophilization. Aim 2 will assess the impact of MCM delivery of mRNA for bone morphogenetic protein
-2/-7 heterodimers in a rat model of a critical size bone defect. Aim 3 will investigate the efficacy of R-
Spondin-2 mRNA on a rat model of composite muscle and bone injury. Outcomes will focus on 1) transfection
after simulated accelerated degradation studies, 2/3) gene expression as well as radiographic,
biomechanical and histologic bone healing. The goal of this work is to improve storage and application of
materials guided mRNA therapeutics for bone regeneration. The proposal will combine the biomaterials and
orthopedic expertise of the proposal sponsor, with the vast medical, scientific, graduate training and
translational resources available at the University of Wisconsin – Madison. This pre-doctoral fellowship will
provide for the development of research, clinical, mentorship, innovation, and communication skills
necessary for a career as an independent physician scientist.

Public health relevance
PROJECT NARRATIVE Non-healing bone fractures are a significant source of personal, economic, and healthcare system burden, especially in elderly populations. mRNA is emerging as a new strategy for regenerative medicine but may be improved with biomaterial carriers. This proposal will characterize mineral coated microparticles as a vehicle to decrease the reliance of mRNA therapeutics on freezers and for mRNA stimulation of bone defect healing.